Heterogeneity in bacterial quorum sensing during infection

PROJECT SUMMARY
Animals harbor bacterial symbionts that express specific traits that promote host fitness. How hosts select
for bacteria with those traits remains poorly understood. A particularly useful model system to examine host-
microbe symbioses is the symbiosis established between the Hawaiian bobtail squid Euprymna scolopes and
the bioluminescent bacterium Vibrio fischeri. The host harbors population of V. fischeri within a specialized
light organ. In exchange for bioluminescence, the host provides the bacterial symbionts with nutrients that
promote their growth. The overall goal of this proposal is to increase understanding of how squid select for
bioluminescent symbionts. Previous work has shown that mutants that lack the light-producing enzyme
luciferase are able to colonize the light organ but become attenuated. Research efforts with mutants that lack
key factors that enable resistance to oxidative stress will be examined in colonization experiments. A screen to
identify systems of nutrient import that is linked to the generation of oxidative stress will also be performed.
Together, these results will determine the physiological changes that affect nonluminous strains, which will
increase understanding of how hosts select for functional symbionts. The candidate will receive training in
microbiology research and opportunities for professional development, which will prepare the candidate for a
career in microbiology research.

Public health relevance
PROJECT NARRATIVE Animals form symbiotic relationships with bacteria, but the mechanisms that enable the host to select for functional symbionts remains poorly understood. The proposed research investigates a sulfur-based strategy for a host to eliminate bacteria that lack the symbiotic function. The research findings will determine the extent to which sulfur utilization promotes host colonization, thereby informing strategies that target these factors as a way to affect host-microbe interactions.